Mechano-Instructive Material Inclusions to Direct Meniscus Repair

Career Development and Mentoring: My long-term goals are to become an independent
scientist/professor at a Veterans Affairs Medical Center in proximity to academic universities for expanded
scientific collaborations and to develop and translate novel therapeutics for improved treatment of problematic
orthopaedic injuries. In my doctoral training, I fine-tuned my skillset in small animal models, multi-scale
biomechanics, and molecular biology techniques (e.g., microarrays). From the proposed Research Plan, I will
expand my research skillset by answering fundamental questions about meniscus repair and cell-material
interactions both in vitro and in vivo using large animal models. Additionally, with strong support from my
Mentor, Dr. Robert Mauck, PhD, and my Co-Mentors, Dr. Carla Scanzello, MD, PhD, Dr. Jason Burdick, PhD,
Dr. Miltiadis Zgonis, MD, Dr. Lin Han, PhD, and Dr. Daeyeon Lee, PhD, I will gain diverse mentorship for my
career development, networking, and research on meniscus pathology, large animal models, and biomaterial
synthesis.
Research Plan: The extracellular microenvironment of meniscus cells determines their fate and health.
Meniscus injury and disease disrupt the native structural and mechanical properties of the microenvironment,
leading to loss of tissue function and chronic pathology. To restore meniscus function, this proposal designs
materials that not only restore the native microenvironment at time zero but also recruit cells and subsequently
promote matrix production following meniscus injury. For this, we utilize material-directed strategies to deliver
biophysical cues that beneficially tailor meniscus cell mechanobiology and behavior. Specifically, we first
develop methods to establish stiffness gradients at the wound edge using infiltration of peptide-modified
hyaluronic acid hydrogels to increase 3-dimensional cell mechano-signaling, motility, and contractility (e.g., 3D
durotaxis). Next, once cells have migrated to the wound margin, we promote matrix production via presentation
of transient mechanical cues as well as increased surface area for cell attachment using cell-adhesive and -
degradable micro-inclusions of tunable size and stiffness encapsulated within the bulk hydrogel. Finally, we
carry out pilot studies to establish the efficacy of these new technologies in a large animal model. Completion
of this work will establish a novel treatment for otherwise irreparable meniscus injuries via a set of mechano-
instructive materials to reestablish the cell microenvironment with high feasibility for rapid clinical translation
and broad implications for meniscus mechanobiology and repair. In summary, my proposed research plan,
mentoring plan, as wells as the outstanding environment and facilities at the Philadelphia VA Medical Center
and the University of Pennsylvania will help me to accomplish my career plans to be a successful VA-based
independent scientist.

Public health relevance
The knee meniscus has high injury prevalence and poor intrinsic healing capacity, yet no clinically available strategies improve endogenous, cell-mediated meniscus healing. Although tissue engineers have developed complex strategies for complete meniscus replacement, cost-effective and functionally integrated strategies for augmented meniscus repair remains a significant challenge. This work employs a practical, materials-focused intervention inspired by well-defined principles in mechanobiology and large-scale cell culture to promote endogenous, cell-mediated meniscus repair via cell migration, proliferation, and integration at the injury site.